The Molecular Biology and Genotyping Core

ABSTRACT
The Molecular Biology and Genotyping Core
The objective of the Molecular Biology and Genotyping Core is to enhance the capabilities of individual
laboratories in conducting vision science research that requires genotyping of mouse models and use of other
molecular biology methods. Accordingly, the Specific Aims of this Module are as follows: 1) to provide a
centralized location and support for mouse genotyping; 2) to train researchers and provide individual laboratories
with assistance in their molecular biology projects; and 3) to provide training and access to shared in the Core
molecular biology and other equipment. The availability of this Core, run by highly experienced personnel, helps
VSRC investigators to efficiently manage their mouse colonies, reduce the cost of mouse housing, detect and
eliminate undesired mutations, increase the utility of mouse models in their research, and ultimately make their
science more cost-efficient and biologically relevant. Time- and resource-saving services of the Molecular
Biology and Genotyping Core are of great value to vision researchers at Case.